Sex differences in cardiac autonomic remodeling after myocardial infarction

ABSTRACT
Cardiovascular diseases, including ventricular arrhythmias and heart failure, are an important cause of
morbidity and mortality in the U.S. Ventricular arrhythmias (VT/VF), after myocardial infarction (MI) and in the
setting of cardiomyopathy, remain an important cause of sudden cardiac death (SCD). While important sex
differences in the incidence of SCD and VT/VF exist in the setting of ischemic and non-ischemic cardio-
myopathy, the mechanisms behind these sex differences remain unknown. It is established that the autonomic
nervous system plays an important role in the genesis of VT/VF and progression of heart failure. Chronic
sympathetic activation and reduced parasympathetic function increase the risk of VT/VF and SCD.
Pathological autonomic neural remodeling in response to MI alters myocardial responses to catecholamines,
modifies myocardial innervation patterns that exacerbate electrical heterogeneities, and leads to alterations in
sympathetic and parasympathetic efferent and afferent signaling, setting up the substrate for VT/VF and its
dynamic modulation by the autonomic nervous system. Yet, it is unknown if there are sex differences in cardiac
autonomic remodeling that underly the clinical differences observed in the presentation and outcomes of
VT/VF after MI and in ischemic cardiomyopathy in men vs. women, and whether the sex hormone, estrogen, is
a mediator of these differences. In order develop tailored and targeted therapies, it is critical to understand
mechanisms that underly sex differences in sympathetic and parasympathetic dysfunction in the setting of
cardiac disease. In this proposal, we aim to test the novel hypotheses that (1) sex differences exist in
cardiac autonomic remodeling after MI and that these differences underly the occurrence of ventricular
arrhythmias in males vs. females, and (2) estrogen plays a critical role in responses of the autonomic
nervous system to myocardial injury, and hence pathogenesis of ventricular arrhythmias. In specific
aim 1, we will test whether myocardial signaling in response to sympathetic and parasympathetic
neurotransmitters and neuropeptides differ between male and female infarcted mice using optical mapping and
novel FRET imaging techniques of intracellular cyclic AMP signaling. In aim 2, we will test whether sex
differences exist in (i) cardiac innervation patterns (using tissue clearing), (ii) afferent and efferent responses to
optogenetic stimulation of specific autonomic neural pathways, and (iii) autonomic ganglia neuronal changes
and oxidative stress after MI. Aim 3 will evaluate the role of estrogen in improving MI induced myocardial and
autonomic remodeling. Understanding sex differences in these fundamental autonomic and myocardial
pathways has the potential to accelerate development of personalized, novel, sex-based disease-modifying
therapies and tailor available therapies more appropriately by sex, reducing complications and side-effects.

Public health relevance
RELEVANCE TO PUBLIC HEALTH The nervous system of the heart plays a key role in the development and progression of heart failure and occurrence of dangerous heart rhythms, such as ventricular arrhythmias, that lead to sudden death. Differences exist in both occurrence and outcomes of ventricular arrhythmias in men vs. women, yet the mechanism behind these differences remain unknown. The current proposal is aimed at identifying sex-specific remodeling in the heart and its nervous system after cardiac injury and associated hormonal factors that may play a role in this remodeling, in order to provide important mechanistic insights as to the observed differences in occurrence of sudden death and progression of heart failure in males vs. females.